Aflatoxin Exposure, Growth Faltering, and the Gut Microbiome among Children in Rural Guatemala

Project Summary
Aflatoxin B1 (AFB1) is a carcinogen produced by Aspergillus flavus and A. parasiticus which grow on maize.
Given the high prevalence of stunting and other nutritional disorders in low- and middle-income countries where
maize is highly consumed, the role of aflatoxin exposure is worth investigating. Observational reports have
shown associations between aflatoxin exposure and child growth. However, most have been cross-sectional and
have not assessed seasonal variations in aflatoxin, food preparation, and dynamic changes in growth. In
addition, biological mechanistic data on how aflatoxin may exert impact on growth is missing. We will advance
the science of aflatoxin and child growth by assessing temporal changes in diet, aflatoxin exposure, and
growth faltering in a prospective cohort of children from rural Guatemala, a country that has one of the
highest rates of child stunting and aflatoxin exposure in the world. In addition, we will use bioreactors to
investigate possible biological mechanisms, specifically direct aflatoxin-gut microbiome interactions.
We hypothesize that aflatoxin exposure negatively impacts child growth by inducing inflammation and disrupting
the gut microbiome. In Aim 1, we will prospectively evaluate aflatoxin exposure and height-for-age difference
trajectories among 185 children between 6-9 and 24-27 months of age. We will assess aflatoxin exposure using
serum AFB1-albumin adduct levels, and we will measure biomarkers of systemic and gut inflammation. In Aim
2, we will evaluate the association between aflatoxin exposure, stunting status, and gut microbiome composition
and function. We will evaluate the fecal microbiome of each child using 16S rRNA gene amplicon and whole
genome sequencing to identify key species and metabolic pathways for differing AFB1 exposure levels and
stunting status. In parallel, we will use bioreactors inoculated with fecal samples to evaluate the response of the
gut microbiome composition to varying levels of AFB1 exposure. In Aim 3, we will evaluate the impact of aflatoxin
exposure on microbial nutrient metabolism and the impact of gut microbiota on aflatoxin
detoxification/metabolism by monitoring key nutrient metabolites (e.g., short-chain fatty acids) and AFB1
biotransformation products in bioreactors. We will also evaluate the effect of inflammation, aflatoxin, and
microbiome composition on child stunting based on the results from the three aims using path analysis.
Significance and Innovation: Through a multidisciplinary approach that leverages access to an exposed
population and expertise on epidemiology, toxicology, environmental engineering and human microbiome, we
will be able to evaluate the impact of aflatoxin exposure on growth and its possible mediation by the gut
microbiome.
Impact: Completion of this R01 proposal will advance understanding of the physiologic mechanism of aflatoxin-
mediated growth restriction, pointing the way toward new public health strategies for mitigation of aflatoxin
exposure and for microbiome-directed treatments.

Public health relevance
Project Narrative We propose to study the role of aflatoxin exposure on child growth, and whether the effect of aflatoxin is mediated by the gut microbiome and inflammation. We will evaluate aflatoxin exposure and height-for-age difference trajectories among children between 6-9 and 24-27 months of age, and will examine markers of inflammation, gut microbiome composition and function, and microbial nutrient extraction and aflatoxin microbial biotransformation. Through a multidisciplinary approach that leverages access to an exposed population and expertise in epidemiology, pediatrics, toxicology, environmental engineering and human microbiome, and bioreactors as model system, we will be able to gather evidence that can be practice- changing, as it will help support large-scale investments in aflatoxin remediation efforts on the part of CDC, USAID and other international public health organizations working to improve global child health.